Investigation of Unusual Cyclization Reactions in Biocatalysis

ABSTRACT

Natural products have been and continue to be a rich source of lead compounds for the treatment and study of
human diseases. Many of these compounds have unusual cyclic skeletons on which their biological properties
depend and often require equally unusual enzyme-­catalyzed reactions for their construction. By mapping the
biosynthetic pathways of these natural products and elucidating the chemical mechanisms of the reactions
therein, we aim to enrich the repertoire of tools available to natural product chemists and synthetic biologists in
their efforts to develop and engineer new technologies and pharmaceuticals for the benefit of human health.
However, in order to fully realize the potential of natural product biosynthesis, the pathways must be
characterized, and the underlying chemistry thoroughly understood. In this spirit, we have identified three
principal systems for study in the next funding period. Thus, the first specific aim is to explore the
unprecedented biosynthetic pathway of ladderane lipids. The cis-­fused cyclobutane ring systems of the
ladderanes have long been of interest to scientists given their importance in anammox bacteria, their impact on
the global nitrogen cycle and their potential as biofuels. However, their biosynthesis remains enigmatic as the
necessary enzyme transformations are essentially unknown and may very well involve a number of radical-­
mediated reactions catalyzed by radical SAM enzymes. The second specific aim seeks to understand the
biological origin of two unique peptidyl nucleoside antibiotics (PNAs). Polyketide and carbohydrate
biosynthesis have traditionally been considered two separate paradigms in secondary metabolism. However,
recent biosynthetic investigations of amipurimycin and miharamycins have suggested that the high-­carbon
sugar cores of these PNAs are likely biosynthesized as polyketides. We aim to rigorously test this hypothesis
by reconstituting the biosynthetic pathways in vitro. We will determine the origin of the sugar cores in these
compounds and establish the sequence and nature of the reactions involved in their construction. The third
specific aim is to elucidate the pathway and reactions that are responsible for pyrazole ring formation in
formycin A and pyrazofurin. The pyrazole moieties in these C-­nucleoside antibiotics are notable for their N–N
linkage that may require formation of an organohydrazine intermediate. However, the biological
transformations underlying N–N bond formation and cyclization are presently almost entirely speculative.
Thorough investigation of these hypotheses will require the collective application of our expertise in molecular
biology, chemical synthesis and enzymology to establish the biosynthetic pathways and enzymatic
mechanisms of catalysis. These systems have been selected on the basis of their novelty, implications for the
field of mechanistic enzymology, and potential utility in biomedical research at the basic and translational
levels. We believe this work will continue to address standing questions in biological chemistry and open new
avenues of discovery in secondary metabolism and pharmaceutical research.

Public health relevance
Project Narrative The proposal seeks to understand the natural formation of a number of unusual ring-containing compounds that are also notable for their established relevance with respect to antimicrobial development (amipurimycin, miharamycins, formycin A, pyrazofurin), anticancer properties (pyrazofurin) and biotechnology such as biofuels and the bioremediation of nitrogen-contaminated wastewater (ladderanes). Given their unusual chemical structures, the biosynthesis of these compounds cannot be understood in terms of currently recognized paradigms of metabolism and enzyme catalysis. This gap in understanding will be addressed by the proposal such that these and related compounds may be further developed for biomedical and biotechnological purposes.